Examining a Unique Contractile Injection System Mediating Host-Microbe Interactions

Project Summary
Bacteria within the human microbiome typically benefit the host. However, an imbalance of some
bacteria groups such as Bacteroidales can lead to diseases like obesity and inflammatory bowel
disease. A current grand challenge in the microbiome field is to identify products produced by
microbiome bacteria that tip this health-to-disease balance. The lack of knowledge about these
products is a significant barrier to improving therapies that modulate our microbiome (e.g. fecal
transplants)—a current area of intense investigation. The objective of my laboratory is to identify
products from normal microbiome bacteria that promote health or disease and determine their
mechanisms of action. To this end, we discovered a previously undescribed family of Contractile
Injection System that bacteria use to naturally promote the development of an invertebrate host
(a tubeworm called Hydroides elegans). Contractile Injection Systems work by injecting
stimulatory effector proteins into host cells that either promote development or elicit disease. This
new family of Contractile Injection System is unique because they exclusively target eukaryotic
organisms (e.g. amoeba, insects, tubeworms). Until now, this family of Injection System was not
known to occur in human-associated bacteria. However, we recently discovered that the gut
microbiomes of nearly all human adults (>99%) from the United States and Europe carry a closely
related, yet previously undescribed Contractile Injection System. Moreover, our in vitro
experiments show that Contractile Injection Systems in Bacteroides bacteria promote human cell
line proliferation and inflammatory responses. In this proposal, we will lay the foundation for
determining the impact of these newly discovered Contractile Injection Systems on human health.
Our central hypothesis that this new Injection System family comprise a key means of interaction
between microbiome bacteria and host, promoting both development and disease depending on
the effectors deployed and context of interaction. Efforts for the next five years focus on (Project
1) investigating the functions of Subtype-4 CIS effector proteins and link effector activity with the
host’s cellular responses; (Project 2) determining how this class of CIS binds to eukaryotic cells
using fibers that structurally resemble eukaryotic cadherin proteins; and (Project 3) elucidating
the structure-function relationship of Subtype-4 CIS from human gut Bacteroidales using cryo-
electron tomography and fluorescence microscopy. Our results will lay a foundation for technology
employing Bacteroidales bacteria and their Contractile Injection Systems as probiotics to
modulate the human microbiome and host health.

Public health relevance
Project Narrative: An imbalance of certain bacterial groups within the human gut is associated with diseases such as obesity and inflammatory bowel disease, however, we lack a mechanistic understanding of these associations. This project will determine how human gut bacteria interact with their host by producing a previously undescribed syringe-like structure that promotes interactions by injecting proteins into target cells. Our results will lay a foundation for technology employing microbiome bacteria and their syringe-like structures as probiotics to modulate the human microbiome and host health.